PSYCHOSOCIAL ASPECTS OF SODIUM EXCRETION/SENSITIVITY IN BLACKS

The purpose of this study is to examine the influence of socioeconomic status (SES) on resting sympathetic nervous system (SNS) activity, stress-induced cardiovascular reactivity, sodium excretion, and sodium sensitivity in black females. It will also explore the interactive effects of a sodium load and chronic stress on acute vascular reactivity.